MMPC-Live Consortium Marketing and Outreach

MMPC-Live Consortium Marketing and Outreach
ABSTRACT and SCOPE OF WORK
The Mouse Metabolic Phenotyping Center (MMPC)-Live at the University of California, Davis is pleased to
submit this administrative supplement for up to 2 years of support in response to PA-20-272, “Administrative
Supplements to Existing NIH Grants and Cooperative Agreements” specifically related to support marketing
and outreach activities in support of the MMPC-Live National Consortium. The mission of the MMPC-Live
Consortium is to serve the research needs of research scientists using mice and mouse models to study and
decipher the heterogeneity of diabetes, obesity, and related metabolic disorders in humans. To that end, this
application proposes implementation of a concerted, organized, and comprehensive outreach plan to broaden
awareness of the MMPC-Live Program beyond the host institutions of MMPC-Live Centers and instead among
the broader national research community. This plan includes focused in-person outreach by exhibiting at
scientific meetings and conferences, distribution of physical materials about the new MMPC-Live and Vibrant
Programs both in-person and online, and the production and distribution of a slide set that MMPC-Live staff
can incorporate into their research and other talks at large meetings, conferences, and other venues of
opportunity. Specifically, this supplement would provide part time effort support for a dedicated and
experienced outreach coordinator (Dan Port), travel and accommodations for up to 5 meetings per year,
redesign and display of the pre-existing MMPC information exhibit booth to represent the MMPC-Live
Consortium, purchase, drafting and distribution of brochures, slides, and other materials relevant to the MMPC-
Live Program, and produce and broadcast professional informational and scientific webinars and other
communication strategies to the broader research community.

Public health relevance
MMPC-Live Consortium Marketing and Outreach PROJECT NARRATIVE This proposal from the Mouse Metabolic Phenotyping Center (MMPC)-Live at the University of California, Davis seeks to address the necessity for a systematic, unified, and extensive outreach plan to accelerate and expand awareness of the MMPC-Live Consortium and National Program within the broader scientific research community. Funding is requested for two years in response to NIH PA-20-272, “Administrative Supplements to Existing NIH Grants and Cooperative Agreements”. Specifically, this application requests funds to 1) provide part time effort support for a dedicated and experienced outreach coordinator; 2) travel and accommodations to deploy and exhibit an MMPC-Live Information Booth at up to 5 scientific meetings per year, 3) purchase, drafting and distribution of brochures, slides, and other materials relevant to the MMPC-Live Program, and 4) professional production and broadcast of informational and scientific webinars and other communication strategies. These activities will raise awareness and inform the research community about the MMPC-Live Consortium and National Program, especially the nascent Vibrant Program, and increase the capability and services of the MMPC-Live Consortium of Centers to meet the needs of the biomedical research community conducting NIH-funded research using mouse models to study the heterogeneity of diabetes and obesity.